Transgenic Core

A. Purpose ¿ To provide a service facilitv that will utilize investigator-derived DNA constructs or investigator derived (or obtained) genetically modified embryonic stem cells to create founder transgenic and gene knockout or knockin mice (i.e mice bearing point mutants, lox-modified or ires/2A-Cre knockin alleles) that can be used to address questions relevant to obesity, diabetes and nutrition, including questions related to brain control of feeding, metabolism and reward. ¿ To provide consultation and training on all aspects of making and using genetically modified mice.